GROWTH HORMONE THERAPY IN CHILDREN WITH SHORT STATURE

Basal studies to evaluate somatomedin, thyroid function, endogenous growth and hormone secretions in Turner's Syndrome patients. Growth hormone response to provocative stimuli, and responses to growth hormone therapy.